A Circulating Biomarker for use in Monitoring Metastatic Breast Cancer

Cost-effective and minimally invasive monitoring of metastatic breast cancer (MBC) patients for disease
progression or response to therapy is an unmet need in the clinical management of the disease. Imaging
technologies are currently the gold standard of such monitoring. However, there is controversy regarding the
type & frequency of imaging required. Imaging is expensive, time consuming, slow to detect disease changes
and raises concern about repeated radiation exposure and costs are not always covered by insurance.
Complementary approaches to imaging such as circulating tumor cells and biomarkers are used in the Standard
of Care (SOC), although their application remains limited. A simple, cost-effective blood test to measure the level
of biomarkers which are drivers of the disease aggressiveness should provide novel solutions for real-time
monitoring of therapy response and reduce dependency on imaging in the MBC population. The PI has identified
an 88kDa glycoprotein GP88 (progranulin), elucidated its biological activity as an autocrine growth & survival
factor. GP88 is secreted from cancer cells and measurable in biological fluids at higher levels in breast cancer
patients, compared to healthy individuals. Based on these characteristics, an innovative diagnostic test (Enzyme
Immunoassay – EIA) to measure GP88 in circulation was established. Our SBIR Phase 1 retrospective study
demonstrated a statistical association between serum GP88 levels measured by the EIA test and objective
measures of disease, i.e. RECIST 1.1 in 101 MBC patients. We established that a serum GP88 level of 56ng/mL
was a stratification point below which patients have improved overall survival while patients with GP88>56 ng/ml
have a poor outcome. We showed that serum GP88 levels were statistically correlated to response to therapy in
addition to progression of disease unlike the SOC biomarker CA15-3 which is only associated to progression of
disease. Based on these promising data, we are proposing an SBIR Phase 2 prospective longitudinal study over
a 15-month period enrolling 120 MBC patients at two clinical sites by measuring serum GP88 level every month
with imaging performed every 3 months. The objectives are to validate the findings of phase 1 and establish the
predictive use of the GP88 test in monitoring MBC patients for disease progression/ response as an adjunct to
imaging and aid in the clinical management of such patients. Specifically, we will (1) Validate that serum GP88
levels are correlated to disease response/ progression as defined by imaging results; (2) Examine the impact of
successive high (>56ng/mL) and low (<56ng/mL) GP88 blood levels on future response/ progression and time
to progression as defined by imaging results; (3) Validate that patients with consistent low (<56ng/mL) GP88
blood levels, have improved survival compared with patients with consistently high (>56ng/mL) GP88 blood
levels. The outcomes of this phase 2 will be to establish clinical data to support commercialization of GP88 EIA
as an integral part of clinical management of MBC patients that will contribute to improved care of MBC patients
at reduced cost.

Public health relevance
There are ~40,000 deaths each year attributed to breast cancer of which 30,000 are as a result of metastatic cancer. The ability to detect disease progression is important in the overall management of metastatic breast cancer patients. While imaging remains the gold standard for monitoring disease status, it is expensive, time consuming, slow to detect disease response or progression and there is concern about repeated exposure to the associated radiation. Alternative approaches complementary to imaging have been considered or introduced in the practice although their application in the Standard of Care remains limited. Monitoring of disease status could be vastly improved by the measurement of biological markers involved in the disease process. We have demonstrated that blood levels of such a biomarker, GP88, are correlated with objective measures of disease status. In this Phase 2 grant application, we are proposing a longitudinal study to enroll 120 metastatic breast cancer patients to examine prospectively the ability of the GP88 blood test to monitor disease status and predict response to therapy or progression of the disease in real time. If we are successful, we will provide to the patients and their treating oncologists a novel solution for patient monitoring in the form of a simple cost-effective and minimally invasive blood test to predict changes in disease status ahead of restaging by imaging. This alone will be a significant step in the clinical management of MBC patients by providing information on the patients’ disease status resulting in lowering exposure to radiation, decreasing toxicities of unnecessary drugs and improving quality of life for MBC patients.